Leveraging Artificial-Intelligence to Profile and Enhance Phenotypic Plasticity for Second Injury Prevention: An Innovative Precision Medicine Platform to Revolutionize Injury Care

Project Summary/Abstract The best predictor of future injury is previous injury. Unfortunately, this has not changed in a quarter century, despite the introduction of evidence-based medicine and the associated revisions to post-injury treatment and care. Nearly nine million sports-related injuries occur annually, and the majority of these require medical treatment and/or clinical intervention prior to clearance for the athlete to return to play (RTP). Even with formal care, injured athletes are two- to four times (in extreme cases 100 times) more likely to suffer a second injury for up to two years after RTP. This is even more alarming given that 65% of initial sports-related injuries affect children and young adults (ages 5-24 years), setting them up for a lifetime of negative health outcomes. These data implicate the initial injury event as the tipping point for a post-injury cascade of negative sequelae exposing athletes to more physical and psychological pain, higher medical costs and greater risk of severe long-term negative health throughout their life. Thus, an urgent need exists to revolutionize the current standard of post- injury care through better identification and targeting of deficits that underlie second injury risk to enable everyone to stay physically active and healthy for their whole lives. To address this need, we propose a pioneering approach that capitalizes on the biological concept of Phenotypic Plasticity (PP) to quantify an athlete’s functional adaptability across different performance environments. Here PP is computed based on both intrinsic and extrinsic factors that reflect the functional movement capability of the athlete. The overall objective of this proposal is, therefore, to develop a generalizable PP-based precision sports medicine approach for second injury prevention through the development of a systematic bioinformatics-driven approach for PP profile construction, and the training of genetic fuzzy artificial intelligence to establish treatment type and magnitude for precision enhancement of PP. The result of the proposed work will be a generalizable PP-based precision sports medicine approach via two expected outcomes: (1) a formalized phenotypic precision medicine approach to objectively quantify behavioral plasticity, and (2) the successful implementation of a platform leveraging genetic fuzzy artificial intelligence integrated with mixed reality for performance prediction. This platform will support delivery of personalized treatments for PP enhancement. These objectives are the critical first step for the development of a generalizable precision medicine approach that will revolutionize rehabilitation and finally stem the tide of second injury in sport. This contribution will be significant to push back against the initial injury tipping point and, in doing so, create a pathway for injured athletes to return safely to physical activity and to maintain a long-term healthy lifestyle.

Public health relevance
Project Narrative The proposed research is relevant to public health because the proposed platform will lead to fewer young men and women who suffer from second injury and the negative effects that lead to poorer long-term health. The project is relevant to NIH’s mission because the knowledge gained will be used to optimize new precision assessment and treatment strategies to prevent injury, and this will enhance health and reduce the burden of athletic injury.